Linking genomic, physiological, and behavioral responses using a Drosophila model of heavy metal stress

Contact PD/PI: Everman, Elizabeth
PROJECT SUMMARY
Heavy metal pollution has pervasive environmental, health, and evolutionary impacts. In humans, health risks of
heavy metals ranging from permanent neurological disease to increased morbidity of degenerative syndromes
are exacerbated by poverty and fragile community infrastructure. Physiological responses to heavy metals
including lead, cadmium, and copper have complex genetic architectures, and several heavy metals are known
to hinder learning and alter behavior. However, these behavioral and physiological responses to metal stress
are often considered in isolation, neglecting the specific genetic relationship between metal toxicity and
behavioral response to metal stress. My primary objective is to dissect and characterize this whole organism
heavy metal response by taking an integrative approach to examine the genetic basis of the relationship between
physiological, behavioral, and evolutionary responses to heavy metal stress. The elite genetic model Drosophila
melanogaster is ideal for my research because it shares many heavy metal-responsive genes with humans, it is
extremely facile to conduct large-scale phenotyping assays, and an enormous plethora of sophisticated tools
are available to facilitate in-depth behavioral and genomic experiments. I treat copper as my model heavy metal
because, although required at low levels for normal development and physiological function, it is a common
heavy metal pollutant that is metabolized and bioaccumulated by genes that also interact with lead, manganese,
zinc, and cadmium. With Aim 1, I will disentangle the genetic link between physiological and behavioral
responses to copper stress using a large mapping panel of genetically stable strains and combining large-scale
screens of multiple behavioral traits with physiological data collected across multiple life stages. With Aim 2, I
will characterize genetic and coevolutionary responses to copper selection in multiple populations derived from
high and low copper resistance natural populations. Aim 2 will involve an evolve and resequencing (E&R)
approach coupled with bulk RNA barcoding and sequencing (BRB-seq) to track the dynamic shifts in allele
frequencies and gene expression through the course of artificial selection for copper resistance. Investigation of
the evolutionary processes that lead to complex trait variation has great biomedical significance as we seek to
understand the gene-by-environment interactions, genetic constraints, and genetic risk factors that contribute to
increased susceptibility to toxic heavy metal exposure in human populations. This integrative approach leverages
QTL mapping, whole genome and RNA-seq, sophisticated functional validation tools available for the D.
melanogaster model system, and experimental evolution. This work will ultimately allow for the characterization
of genetic variation in chemosensory ability, traits related to decision making, and neurological function in
response to copper stress in diverse synthetic and naturally derived genetic backgrounds. Together, these
approaches will provide critical insight into the interconnectedness of multiple response traits, while also
illuminating genetic factors that influence behavioral and learning disabilities linked to metal poisoning.

Public health relevance
Contact PD/PI: Everman, Elizabeth PROJECT NARRATIVE Mapping quantitative trait variation to specific genes has proved critical for our understanding of the genetic basis of disease in humans, and the same approaches can be used to identify genes and networks that are responsible for variable resistance to metal poisoning in natural populations. Here I will combine powerful, highly replicated genetic mapping with multiple behavioral and physiological assays and whole genome and RNA sequencing to characterize the genetic basis of resistance to copper poisoning. By exploiting an elite model genetic system, this work will provide novel insight into genetic variants that influence susceptibility to metal poisoning in humans.